Telomere uncapping epigenetically reprograms a stress response and longevity pathway

Summary
Interstitial Telomere Sequences (ITS tracts) are degenerate telomere repeat tracts found on metazoan
chromosome arms whose functional significance is not known. We propose to develop a new paradigm in the
field of telomere biology, by demonstrating a telomere binding protein in somatic cells regulates a suite of
stress response and longevity genes that possess introns with ITS tracts. We discovered that ITS tracts are
enriched in the introns of C. elegans genes, and this is also true in humans. We identified hundreds of C.
elegans genes with ITS tracts that are bound by a telomere binding protein. The vast majority of these genes
are upregulated in response to environmental stresses and in mutants that are long-lived and stress resistant.
We discovered environmental stresses that alter localization of telomere binding proteins to telomeres of
embryos and as well as nuclear localization in somatic cells of L4 larvae. We propose to characterize how
environmental stresses and longevity pathways epigenetically reprogram the expression of genes whose
introns possess ITS tracts, in part by remodeling the structures of ITS tracts of genes with roles in stress
resistance and longevity.
Preliminary data indicate that mutating the single-stranded telomere binding protein pot-1 impedes
binding of all single-stranded telomere binding proteins to telomeres. Moreover, pot-1 mutation also induces
moderate longevity, and both longevity and disrupted telomere capping phenotypes can be transmitted by pot-
1 mutant gametes to multiple generations of progeny that possess wild type POT-1 protein. We propose to
study the heritable consequences of telomere uncapping in pot-1 mutant germ cells on expression of genes
with ITS tracts. We will ask if longevity of long-lived mutants, including pot-1 mutants, grown with or without
arsenic is modified by RNAi silencing of ITS tracts or by re-wiring the expression of dsDNA telomere binding
proteins. We will assess the consequences of telomere uncapping defects of pot-1 mutants as well as arsenic
or copper on telomere stability in the absence of telomerase, on telomere mutations and on T-loop formation.
This work will help to develop a model created by Charles Darwin and Jean-Baptiste Lamark, who
hypothesized that environmental stresses perceived by parents might modify germ cells in a manner that
would improve fitness of their children. This project may reveal that telomere capping as a malleable epigenetic
factor that can be transmitted from parent to child and is coupled to regulation of genes with ITS tracts in their
introns, in a manner that modulates longevity and resistance to environmental stress in future generations.
However, because somatic telomere length shortens as humans age, and because irreparable DNA damages
accumulate at telomeres in the context of human aging, insight into roles of telomere uncapping, arsenic or
copper in modulating expression of stress response and longevity genes with ITS tracts may be relevant to
understanding how normal human aging occurs and can be modulated.

Public health relevance
Project Narrative We found that two environmental toxins of concern to humans, copper and arsenic, disrupt the localization of a telomere binding protein to telomeres of embryos and to nucleoli of L4 larvae. Characterization of responses to copper and arsenic in wildtype and long-lived mutants may reveal that they epigenetically reprogram a suite of stress response genes with ITS tracts, which would provide a valuable novel model for how environment stresses as well as the status of telomere capping might modify longevity and stress resistance in humans, potentially in the context of inheritance.